Consortium on Methods Evaluating Tobacco (COMET): FilterVentilation and Product Standards

ABSTRACT
The 2014 Surgeon General Report (SGR) concluded that there has been an unanticipated increase in lung
adenocarcinomas, now the most common type of lung cancer. The SGR identified ventilation in cigarette
filters, a design introduced in the 1960s and an important way to lower machine measured cigarette tar yields,
as a potential contributor to the increase in these lung cancers. In a recent review, we found highly suggestive
evidence that filter ventilated cigarettes was the cause of the increased incidence of adenocarcinoma lung
cancer and concluded that there was enough evidence for the FDA to consider regulating filter ventilation,
including a ban. Independent of the risk for adenocarcinoma, there would be sufficient justification for
regulation based on the impact of ventilation on harmful constituent yields, smoking behavior and smokers'
misperception of health risks. However, prior to any regulatory action, the consequences of such a ban needs
to be studied. This P01 describes a set of systematic and comprehensive studies that examines the toxicity,
appeal and abuse liability of unventilated filters as compared to ventilated filters in the context of a marketplace
with and without alternative nicotine delivery systems (ANDS). Four integrated projects and three cores are
proposed and involve a team of multi-disciplinary investigators who have worked together in developing
validated models and measures to test tobacco products. The four projects address 1) how unventilated vs.
ventilated cigarettes are smoked and the resulting carcinogen exposure levels and potential harm when used
with and without ANDS (Project 1); 2) the relative abuse liability of these ventilated vs. unventilated cigarettes
and the extent to which ANDS serves as a substitute for unventilated cigarettes (Projects 2 and 3); and 3) the
effects of ventilation and product packaging/messaging on consumer perceptions of harm, response and
uptake and how these perceptions can be modified by ANDS (Project 4). This research is novel in many ways,
including the first to assess the impact of removing filter ventilation and doing this in the context of a complex
tobacco marketplace. The projects that we propose are highly integrated. None of these studies alone can
address the population impact of a ban on ventilation. It is the combination of these complementary studies
that can address the impact of a ban on toxicity, uptake and intensity of product use to determine population
health impact. The results of this study would provide critical information to the U.S. Food and Drug
Administration on whether or not a ban would lead to improved public health.

Public health relevance
NARRATIVE Cigarette filter ventilation has been considered to have led to public health harm. This P01 application describes a series of comprehensive, systematic and integrated projects on the relative toxicity, addictiveness and appeal of unventilated vs. ventilated filter cigarettes. The results from this P01 will provide evidence to the FDA to determine if regulation of filter ventilation should be pursued.